Regulation of viral-bacterial co-infections by immunometabolism

SUMMARY/ABSTRACT
Pseudomonas aeruginosa is a major respiratory pathogen in the pathogenesis of Cystic Fibrosis (CF) and the
ineffective immune response to this pathogen is thought to cause the majority of the lung damage characteristic
of this disease. In the later stages of CF, P. aeruginosa reside in biofilm communities in the lung, accounting for
their resistance to antibiotic therapies. To date, little is known about host factors that promote the transition of P.
aeruginosa from acute to chronic infection in CF. CF patients show a reduced ability to clear P. aeruginosa
acquired during respiratory viral infections and frequently new pseudomonal colonization in people with CF
follows a respiratory viral infection. We have shown that virus co-infection, and the subsequent antiviral interferon
response, promote biofilm conversion by P. aeruginosa. Interferon has potent antiviral activity, but in addition,
interferon stimulated gene (ISG) effector functions have been reported to promote pathogen replication,
suggesting that pathogens have evolved to subvert and even benefit from the interferon response. Decades of
research demonstrate metabolic reprogramming as part of the host response to acute viral infections, with
induction of aerobic glycolysis being a common observation. Our preliminary data suggest that the innate antiviral
immune response through IFN signaling induces aerobic glycolysis during RSV infection, while still maintaining
oxidative phosphorylation in the respiratory epithelium. Using an improved model to culture P. aeruginosa
biofilms in association with human CF airway epithelial cells and a RSV mouse infection model, we will examine
mechanisms by which antiviral interferon signaling promotes biofilm conversion by P. aeruginosa through a
mechanism of metabolic reprogramming. To this end, we will determine how metabolic reprogramming of the
respiratory epithelium facilitates viral-bacterial co-infection, define how secreted metabolic products from the
virus-infected respiratory epithelium promote P. aeruginosa persistence and chronic infection by impairing
antibacterial function in recruited macrophages and promoting bacterial biofilm growth. Our goal is to elucidate
the molecular mechanism for virus-stimulated bacterial biofilms and thus, identify new targets that could delay
acquisition and chronic bacterial colonization, or work in conjunction with existing therapies, to eradicate P.
aeruginosa in CF patients.

Public health relevance
PROJECT NARRATIVE Pseudomonas aeruginosa is the major cause of morbidity and mortality for people with Cystic Fibrosis (CF). Using a specialized model system to culture P. aeruginosa biofilms in association with human CF airway epithelial cells, we have observed that virus co-infections promote chronic infection by P. aeruginosa. The studies proposed in this application will define metabolic changes during viral-bacterial co-infections in the CF airway that promote chronic bacterial infections, and likely identify new therapeutic targets that could be exploited to delay acquisition or work in conjunction with existing therapies, to eradicate P. aeruginosa infections in CF.